Restoring cytoskeletal dynamics to improve circuit integration of transplanted photoreceptors

Project Summary/Abstract
Cell replacement therapies are one of the best options for multifactorial diseases of the retina like aged
related macular degeneration (AMD), which normally cannot be treated by correcting mutations in individual
genes. The retina is also highly surgically accessible, allowing stem cell derived neurons to be precisely
transplanted and tracked post-operatively. While transplant therapies into the retina are ongoing, including
Phase I human trials, success has been limited due to the inability of photoreceptors (PRs) to integrate
properly into complex existing circuits. One potential means to improve PR integration is to transplant
genetically modified PRs that have enhanced ability to extend processes and form synapses. We recently
found that stem cell derived PRs have a limited time they are capable of autonomous axon extension, which
correlated with a loss of an organized actin cytoskeleton within their terminals and an upregulation of synaptic
proteins (Rempel et al., 2022). This result suggests that PRs become immobile due to their decreased ability to
polymerize and organize actin, which is essential for cell and growth cone motility. Therefore, identifying age-
dependent molecular changes that account for the loss of actin filaments and decreased PR terminal motility
would provide potential targets to potentiate intrinsic PR terminal motility. Transplanting more motile older PRs
that also express synaptic proteins could greatly improve circuit integration. It also should be noted that even
young human PRs only extend axons an average of 20 um in isolation, so methods to improve terminal motility
at any age could help restore circuits in the adult retina. Transplantation of “motility enhanced” PRs could
greatly improve their integration into existing circuits. Here we propose a series of innovative experiments to
first test likely upstream modulators that may be lost as PRs mature within retinal organoids (ROs). Next, we
will conduct an unbiased proteomic screen of protein expression changes within PRs across relevant time
points. Candidates will be tested to determine if PR actin dynamics, terminal motility and axon extension can
be enhanced by increasing the activity of key proteins that show age-dependent loss of expression.

Public health relevance
Project Narrative Regeneration of neural circuits requires extension of axons by transplanted neurons and reestablishment of proper synaptic connections onto target neurons. This proposal is focused on understanding the molecular changes that occur within human photoreceptors (PRs) that may be responsible for age-dependent loss of autonomous axon extension. By genetically modifying human PRs, we hope to improve the ability of transplanted PRs to reintegrate into existing circuits within an injured adult retina.